CUSHING'S DISEASE AFTER TRANSSPHENOIDAL SURGERY AND RECURRENCE DETECTION

To evaluate the usefulness of corticotropin releasing hormone and to assess methods for evaluating cure of Cushing's disease after transsphenoidal surgery and methods for detecting early recurrence.